Tulane National Primate Research Center AIDS SPF Breeding Colony Maintenance

Project Summary/Abstract - Overall
The Tulane National Primate Research Center (TNPRC) has one of the largest rhesus monkey breeding colonies
in the United States. The objective of this application is to request funds for continued support and maintenance
of U42-supported specific pathogen-free (SPF) and expanded SPF (eSPF) Indian-origin rhesus monkey
breeding colonies at the TNPRC. The specific aims address the components specified in the Notice of Funding
Opportunity (NOFO) and are divided into the Overall program description, Husbandry and Management Core,
Viral Testing Core, and MHC Genetic Typing Core. Program income and TNPRC funds will be used to support
components of the program not covered by grant funds, including per diem for any colony animals in excess of
the animals supported by this application, additional testing required for those animals, infrastructure repairs and
improvements, veterinary clinical and pathology support, behavioral management support, and portions of the
genetic testing.
Specific Aims:
Overall. To maintain the existing U42-supported SPF and eSPF colonies and distribute available animals to the
NIH-funded HIV/AIDS-related research community.
Husbandry and Management Core. To provide husbandry and veterinary care for the SPF and eSPF breeding
colonies. This includes a robust program for clinical veterinary medical care and behavioral management. The
colonies supported by this U42 have reached a mature self-sustaining status with ideal demographics for
production of up to 105-150 animals available for research assignment each year based on production and
demand with the balance as replacement breeders. Program income generated by the sale of animals will be
returned to an account for use in supporting the aims of the grant.
Viral Testing Core. To assure the SPF status of the colony through continued viral testing of existing breeding
colony animals and all offspring for all four target viruses for the SPF colony (Type D Simian Retrovirus [SRV],
Simian T-lymphotropic Virus [STLV], Simian Immunodeficiency Virus [SIV], and Herpes B virus) plus six
additional agents (rhesus rhadinovirus [RRV], lymphocryptovirus [LCV], cytomegalovirus [CMV], simian foamy
virus [SFV], simian varicella virus [SVV], and simian virus 40 [SV40]) for the eSPF colony. We will also
continue to expand characterization of the colony through application of additional diagnostic assays for other
pathogens of potential interest.
MHC Genetic Typing Core. To continue genetic analysis and MHC typing and provide expanded genetic
characterization through enhanced techniques with the goal of sustaining genetic diversity.

Public health relevance
Project Narrative - Overall Tulane National Primate Research Center (TNPRC) has one of the largest specific pathogen-free (SPF) and expanded SPF (eSPF) rhesus monkey breeding colonies in the United States, a resource that has provided animals for NIH-funded research projects for several decades and is a critical component of the TNPRC’s successful HIV/AIDS research program. Over half of all research projects at TNPRC are initiated by outside investigators, making this resource essential to the success of many NIH-funded projects across the country. Experienced leadership and significant infrastructure investment, combined with proven techniques in breeding colony management, ensure continued responsible stewardship of this nationally recognized resource for HIV/AIDS-related research.